Predicting Post-Operative Pain and Analgesic Use: The Role of Endogenous Opioids

DESCRIPTION (provided by applicant): This Career Development Award (K23) will provide the candidate the necessary training to establish a program of research related to understanding how key neurobehavioral risk factors (i.e., irregular central pain processing, sleep disturbance, and negative thinking) impact neurobiological mechanisms (i.e., endogenous opioid function) that contribute to individual differences in pain outcomes. Chronic pain is a major health problem affecting a significant proportion of the American population and is associated with substantial suffering and economic burden. Sleep disturbance, mood, and aberrant central pain processing have been identified as important predictors of chronic pain and disability, and have been indirectly associated with impaired endogenous opioid function. The proposed research plan will systematically address the utility of a direct pre-surgical test of endogenous opioid function via naloxone challenge in predicting pain and opioid analgesic use following total knee arthroplasty (TKA) in patients with knee osteoarthritis (OA), one of the most prevalent chronic pain conditions and predicted to drastically increase as the U.S. population ages. Specific training aims of this K23 include mentorship, didactics, and experiences designed to develop expertise in the neurobiology of pain, opioid blockade and sleep assessment methods as well as develop a solid foundation in biostatistical analyses. No research to date has examined the relationship between abnormal central pain processing, sleep disturbance, and mood with impaired endogenous opioid function. Consequently, the proposed research plan intends to investigate whether these risk factors share a neurobiological substrate that links them to important clinical pain outcomes following TKA, including persistent post-TKA pain, and increased opioid use. In particular, the proposed study will systematically evaluate the effectiveness of a direct pre- surgical test of endogenous opioid function via naloxone challenge in predicting post-operative pain and opioid use following TKA. Additional work will examine whether endogenous opioid function is associated with abnormal central pain processing, sleep disturbance, and pain related negative thinking on pain. Understanding the risk factors and underlying mechanisms whereby they exert their influence on outcomes following TKA, will have important implications for the selection of surgical patients, inform the management of post-operative pain, improve the health-related quality of life of individuals with chronic pain, and assist in the development of interventions designed to reduce the impact of the risk factors studied in this proposal. The candidate's long term goal is to refine biopsychosocial models of pain and facilitate the development or enhancement of therapeutic interventions for post-operative pain and to prevent chronicity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Osteoarthritis (OA) affects 20 million older Americans and the prevalence of knee OA is projected to dramatically increase as the U.S. population ages. Pain is the most common symptom associated with degenerative joint disease and is aggravated by abnormal functioning of central pain modulatory systems, sleep disturbance, and negative thinking. The proposed study will increase understanding of the mechanisms by which these factors impact pain related outcomes following total knee arthroplasty (TKA). Findings from this study will be used to alter modifiable risk factors associated with the development of chronic pain and to develop and refine psychosocial interventions for post-operative pain. Narrative Osteoarthritis (OA) affects 20 million older Americans and the prevalence of knee OA is projected to dramatically increase as the U.S. population ages. Pain is the most common symptom associated with degenerative joint disease and is aggravated by abnormal functioning of central pain modulatory systems, sleep disturbance, and negative thinking. The proposed study will increase understanding of the mechanisms by which these factors impact pain related outcomes following total knee arthroplasty (TKA). Findings from this study will be used to alter modifiable risk factors associated with the development of chronic pain and to develop and refine psychosocial interventions for post-operative pain. __SpecificAimsTextDelimiter__ Research Plan Specific Aims Chronic pain affects approximately 20% of the US population and exacts significant personal suffering and healthcare burden. Surgical interventions are commonly used to ameliorate chronic pain. However, for a number of patients, pain persists. Total knee arthroplasty (TKA) provides an opportune model for studying the risk factors associated with the trajectory of post-operative outcomes, as a subset of TKA recipients experience long-term post-operative pain and extended opioid-based analgesic use. Knee osteoarthritis (OA) is among the most prevalent chronic pain conditions, and this is projected to increase sharply as the U.S. population ages. Hence, identifying predictors of TKA pain and analgesic use outcomes, and their underlying neurobiological mechanisms is essential. In general, individual differences in the trajectory of pain and analgesic use post-TKA are only loosely related to physical examination and radiographic findings. Individual differences in the trajectory of pain and analgesic use following surgery have been well documented. Work by Drs. Haythornthwaite (mentor), Smith and Edwards (proposed consultants for this patient-oriented mentored clinical research award) has identified several potentially important neurobehavioral risk factors for persistent post- operative pain, including aberrant central pain processing, sleep disturbance and negative thinking about pain (e.g., pain catastrophizing). Indirect evidence suggests that these risk factors are associated with impaired endogenous opioid function, which may constitute a shared neurobiological substrate linking these risk factors to persistent post-TKA pain and opioid use. This K23 application proposes to systematically address the utility of a direct pre-surgical test of endogenous opioid function via naloxone challenge in predicting post-TKA pain and opioid analgesic use. Moreover, the role of endogenous opioid system functioning as a key neurobiological mechanism mediating the effects of central pain processing, sleep disturbance and negative thinking about pain on post-TKA pain and opioid analgesic use will be examined. This project will be conducted in the context of a large-scale, recently funded 5-year multi-site prospective cohort study of risk factors for post-TKA persistent pain and functional impairment. The parent grant will conduct multimodal evaluation of sleep quality, continuity, and architecture, a battery of standardized questionnaires, as well as patients' pain and functioning preoperatively, perioperatively, at 1-week, 6-week, 3-month, 6-month and 1 year follow-up assessments. The candidate's K23 research will add detailed monitoring of opioid analgesic use, as well as pharmacologic characterization of endogenous opioid antinociceptive function (i.e., using naloxone) preoperatively and at a 6-weeks post-TKA follow-up. Specifically, knee OA patients scheduled for TKA will undergo a double-blind placebo-controlled naloxone cross-over challenge pre-operatively and at 6-week follow-up to assess endogenous opioid antinociceptive system function. The parent study and the proposed mentors provide the infrastructure and intellectual resources to support that candidate's proposed aims. Collectively, understanding the mechanisms contributing to individual differences in post-TKA outcomes, particularly pain and analgesic use, has important implications for the selection of surgical patients and management of post-operative pain. Aim 1: to examine associations between neurobehavioral risk factors for long-term pain and individual differences in endogenous opioid antinociceptive system functioning. Hypothesis 1: TKA patients with greater pre-surgical disruptions in central pain processing, sleep disturbances and negative thinking about pain will exhibit diminished endogenous opioid functioning as evidenced by smaller opioid blockade effects on laboratory pain sensitivity. Aim 2: to determine whether pre- operative endogenous opioid antinociceptive system functioning predicts outcomes (knee pain and opioid analgesic use) following TKA. Hypothesis 2: Diminished pre-operative endogenous opioid functioning will predict higher doses of opioid medication during the acute post-operative period. Hypothesis 3: Lower pre-operative endogenous opioid functioning will predict greater persistence of knee pain and opioid analgesic use during the 6-month follow-up period (controlling for potential variability in physician prescribing habits). Aim 3: to examine the relationship between neurobehavioral risk factors and post TKA outcomes and investigate the degree to which endogenous opioid function mediates this association. Hypothesis 4: Baseline neurobehavioral risk factors will each be associated with post TKA outcomes and these relationships will be mediated by the degree of baseline endogenous opioid functioning. Hypothesis 5: Change (reduction from baseline to 6-week follow-up) in neurobehavioral risk factors will be associated with positive post-TKA outcomes at 6 months and this relationship will be mediated by change (improvement from baseline to 6-week follow-up) in endogenous opioid function.